Neural Circuit Dissection of Prefrontal Cortex Projections in Social Dominance Behavior

Project Summary/Abstract
Social interactions, reciprocal interactions between two or more individuals, are critical to the physical
and emotional health of a wide variety of species. Perturbations in social functioning, a hallmark symptom of
many psychiatric and neurodevelopmental disorders such as autism and schizophrenia, can profoundly impair
an individual's ability to sustain healthy social relations. However, while disruption in social behavior can arise
as a symptom of such disorders, negative social experiences, such as exposure to antagonistic or dominant
social agents, can also support the development and maintenance of psychiatric disorders, such as depression
and anxiety. Furthermore, expression of dominance behavior during social interactions is strongly linked to
resilience to psychiatric disorders in both rodents and humans—individuals who assert dominance are more
resilient to depressive-like symptoms, while individuals who display subordinate behaviors are more vulnerable
to the debilitating effects of stress. Despite growing evidence of the role that social dominance plays in the
etiology of psychiatric disorders, our current understanding of the neural circuit mechanisms that promote
dominant and subordinate behaviors remains remarkably weak. Published work from our lab and others has
identified the dorsomedial prefrontal cortex (dmPFC) as a critical node for the expression of dominance
behaviors in both rodents and humans. However, how neural computations in the dmPFC that orchestrate social
dominance decisions are relayed to subcortical limbic regions has never been explored. The experiments
described in this proposal will fill a critical gap in our understanding of neural mechanisms for dominance
behavior by performing detailed neural circuit dissection strategies to anatomically map, physiologically observe,
computationally model, and functionally manipulate individual descending projections of the dmPFC during social
dominance behaviors. Specifically, the outlined proposal will 1) utilize in vivo optogenetics to bidirectionally
manipulate dmPFC projections during social dominance behaviors and 2) utilize in vivo freely moving calcium
imaging to optically record projection-defined dmFPC populations during dominance decisions. The proposed
study will reveal how discrete, anatomically-defined pathways descending from the dmPFC are engaged during
social dominance. These results will set the foundation for a more incisive analysis of how dmPFC circuits shape
social function in both health and disease.

Public health relevance
Project Narrative Social dominance behaviors are characteristic of a wide range of species, including humans, and have far- reaching implications on the development and maintenance of psychiatric conditions, such as resilience to depression and anxiety—however little is known about the neural mechanisms underlying social dominance. Using cutting-edge neural circuit dissection tools such as in vivo calcium imaging and optogenetics in mice, this proposal will elucidate how dominant and subordinate social decisions are represented in descending projections of the prefrontal cortex, a critical hub for social behaviors. By recording from and causally manipulating prefrontal projections, this research will enhance our understanding of how social dominance is represented in the brain, and will pave the way for more effective therapeutic strategies for mental health.